PHARMACOLOGY AND PHARMACOKINETIC CONSULTING SERVICE TO THE CONTRACEPTION RESEARCH BRANCH (CRB)

Liaise between various research facilities and NICHD staff to ensure planned studies achieve necessary pharmacokinetic requirements to meet NICHD Contraceptive Research Branch objectives